DONT KNOW RESPONSES TO PERCEIVED RISK ITEMS: IMPLICATION FOR HEALTH BEHAVIOR

DESCRIPTION (provided by applicant): Nearly half of all cancers cases might be avoided if people were to engage in healthy lifestyle and early detection behaviors. A central tenet of theories of health behavior is that awareness of a threat is an important condition for protective action. Empirical evidence supports the idea that higher perceptions of risk motivate people to engage in cancer prevention and detection behaviors. Consequently, an important component of cancer surveillance has been assessing the population's perceptions of risk of developing cancer. Health promotion and education campaigns that seek to promote cancer prevention and early detection behaviors often attempt to increase the public's sense of personal risk of developing cancer. In order to optimize surveillance and develop health education and promotion campaigns that engage those at greatest risk for not engaging in protective behaviors, it is important that we understand the relationship between perceived risk and health behavior for all research respondents. Currently this is not the case. Our research found that at least 16 million people in the U.S. would respond I don't know if asked their perceived risk of developing cancer. Many of these people are members of populations that experience cancer disparities. Little is known about the health behaviors of these individuals because people who respond don't know have typically been dropped from analyses. Thus, these individuals have been systematically excluded from much cancer prevention research. However, if, as our preliminary research suggests, they are unaware of their cancer risk (or unable or unwilling to report it), the may be at increased risk for not engaging in cancer prevention and detection behaviors. Therefore, understanding the relation of don't know responding to engaging in preventive health behavior is a critical research need. To test the hypothesis that don't know responding is associated with lower engagement in cancer prevention and detection behaviors, we will examine the association between don't know responding to risk perception questions and a wide variety of cancer prevention behaviors in 14 large, population-based surveys (i.e., multiple years of NHIS, HINTS, and BRFSS). Specific behaviors include physical activity, fruit and vegetable intake, tobacco use, skin protection, HPV vaccination, cancer screening (breast, colorectal, prostate), and, because AIDS is a risk factor for several cancers, HIV testing. Multivariate linear and logistic regression will be used to estimate the relation between don't know responding to perceived risk questions and engaging in a given cancer prevention or early detection behavior, after controlling for demographic characteristics. This research will address a gap in knowledge about the health behaviors of the 7-10% of U.S. adults -- more than 16 million people -- who respond don't know to cancer risk perception survey questions. The study will also advance our knowledge of why existing intervention approaches may be ineffective for certain populations that experience cancer disparities, as well as identify potential intervention components and target populations for such interventions.

Public health relevance
PUBLIC HEALTH RELEVANCE: It is estimated that, when asked about their risk of cancer, over 16 million adults in the U.S. respond I don't know. This study will test whether these individuals are at risk for not engaging in behaviors that prevent and detect cancer, including cancer screening, physical activity, avoiding tobacco, obtaining HPV vaccination, and eating adequate fruits and vegetables. Findings will indicate whether people who respond don't know are a high risk group that may need to be engaged with targeted health education and promotion.